REGULATION OF ADRENAL FUNCTION IN FIBROMYALGIA

The purpose of this study is to characterize the regulation of adrenal steroid hormone production in individuals with fibromyalgia and Chronic Fatigue Syndrome versus healthy individuals.